Childhood Adversity Research Effort in Multiple Sclerosis (CARE.in.MS)

Project Summary
Nationwide, a widening gap in neurologic health outcomes exists, with minority populations suffering a
disproportionate burden of neurologic disease and in some cases, even seven times greater mortality than
non-minority populations. Here we focus on the neurologic disorder, multiple sclerosis, the most common
disabling central nervous system (CNS) disorder of young adulthood. We have designed a collaborative
research project to work alongside individuals with MS who possess one or more lived experiences within the
most vulnerable minority populations, including but not limited to Black, Hispanic, and poverty-impacted
communities. We posit that childhood adversity experienced at the individual, family, and neighborhood levels
significantly contributes to worse health, particularly among high risk group. Here, we have collaborated with
communities of interest (persons with MS who come from specific high risk minority groups), community
engagement partners, and a highly multidisciplinary diverse research team. Together, we are aligned to
collaboratively develop and execute a comprehensive, culturally-informed multicenter study of childhood
adversity and MS health outcomes involving predominantly individuals who self-identify as members of
minority groups with MS. This community-engaged proposal advances clinical readiness by creating culturally-
sensitive research instruments, meticulously analyzing the relationship between childhood adversity and MS
outcomes, and understanding the environmental and social factors influencing quality of life in high-risk
minority and poverty impacted people with MS. The insights gained will guide the development of tailored
interventions to narrow the health equity gap, ensuring that all individuals with MS have equal opportunities for
optimal health outcomes and quality of life. Identified modifiable targets will be rapidly scaled into a clinical trial
across the U.S. Network of MS Centers.

Public health relevance
Narrative This project addresses the unacceptable health disparity in multiple sclerosis as experienced by members of minority and socioeconomic disadvantaged communities. Working alongside persons living with MS and community engagement partners we focus on the impact of child adversities in MS to identify future community- based interventions.